Characterizing photoreceptor precursor cells for retinal transplantation

PROJECT SUMMARY
Retinal degenerative diseases result in the progressive loss of rod and cone photoreceptor cells.
Because the mammalian retina cannot regenerate, photoreceptor cell death leads to irreversible vision
loss. It is thus critical to improve our understanding of photoreceptor development and to investigate
avenues of photoreceptor regeneration to restore vision. Cell-based therapies involving the
transplantation of healthy donor cells have led to functional improvements in vision and represent a
promising treatment approach to replace retinal cells. However, these efforts have yielded low rates of
donor cell integration, suggesting that the identity of an optimal cell type for photoreceptor replacement is
unknown. To address this knowledge gap, we performed unbiased single cell transcriptomics of the
neonatal retina to understand the fundamental heterogeneity of developing photoreceptor precursor
cells. We identified several novel subpopulations of cone-rod homeobox (Crx)+ cells with transcriptionally
and spatially distinct expression profiles consistent with early (Dll1+), intermediate (Dll3+/Neurod4+), and
late (Prom1+) photoreceptor precursor cells. Our central hypothesis is that these Crx+ subpopulations
represent photoreceptor precursor cells with an increasing degree of lineage commitment to
photoreceptor differentiation, and that isolation of a transcriptionally distinct subset of cells will improve
the efficiency of integration upon subretinal transplantation in a mouse model of retinal degeneration. To
test this hypothesis, we will perform lineage tracing of each subpopulation using inducible Cre
recombination during normal development (Aim 1), and determine which subpopulation can most
efficiently integrate upon subretinal transplantation into a mouse model of retinal disease (Aim 2).
Together, these studies will help define the complex hierarchy of photoreceptor development and identify
an optimal cell source for photoreceptor replacement that is critical to advancing the field of retinal
regeneration in human blinding diseases.

Public health relevance
PROJECT NARRATIVE Retinal diseases are a leading cause of irreversible blindness worldwide and there are currently no treatments to restore vision after photoreceptor cell death. Cell-based therapies to regenerate photoreceptor cells represent a promising treatment approach, but current transplantation strategies have limited cellular integration. This proposal uses single cell transcriptomics, genetic lineage tracing, and transplantation studies to define an optimal population of photoreceptor precursor cells for regenerative strategies which may lead to new potential therapies for blinding diseases.